Administrative Core

Project Summary (Administrative Core)
Continuing funds are requested by 18 vision scientists (holding 20 eligible NEI R01 grants) and their
personnel to support an administrative core and three resource/service cores in the merged Department of
Ophthalmology, Visual and Anatomical Sciences (former Ophthalmology and Anatomy/Cell Biology
Departments). The Administrative core will support the overall management of the Center Core. Its
organizational structure is designed to be sufficiently robust and able to integrate the activities of the three
research (Resource) cores and to determine funds flow and their utilization. The overall administration of the
Core grant will remain the responsibility of the PD/PI, Dr. Hazlett, in concert with the research core directors.
The Administrative core will be used to provide integration, coordination and evaluation of the activities of the
three resource/service cores. The Administrative core will be the vehicle by which we establish priorities,
allocate resources and provide mechanisms to schedule use of a resource/service core among participating
investigators. An External Advisory committee is also in place to provide oversight and review, if the need
occurs. The Administrative core will be staffed by a business manager (for whom partial support is
requested), secretarial and other administrative support to carry out specific activities related to the Core
Vision Grant, which include providing fiscal management and integrating core activities within the institution
and academic administrations. For this activity, two positions, one clerical and the other accounting will
continue to be funded by the School of Medicine General Fund allocation to the Ophthalmology, Visual, and
Anatomical Sciences Department for which Dr. Hazlett has oversight and responsibility to manage and
balance the Research budget as vice chair of the department.